Obesity-induced dysfunction of human MSC in peripheral microvascular repair

Abstract
Obesity triggers cellular damage and impedes tissue recovery from injury, and its escalating prevalence
may promote complications of peripheral vascular disease, such as critical limb ischemia (CLI) or renal artery
stenosis (RAS). Reducing complications of obesity could diminish the risk of death, improve quality of life, and
produce extensive cost savings. This application is based on the scientific premise that obesity increases
tissue susceptibility to injury by interfering with normal defense and repair processes associated with
mesenchymal stem/stromal cells (MSCs). MSCs constitute an effective endogenous cellular repair system,
but obesity may blunt their efficacy. We found that obesity-induced MSC dysfunction in pigs was associated
with altered mitochondrial structure and function, but the mechanisms of mitochondrial damage in human MSC
and its contribution to regulation of MSC function in human obesity remain unknown.
Our central hypothesis is that human obesity engages epigenetic mechanisms that impair human MSC
mitochondrial structure and function and render MSC functionally deficient. We speculate that obesity
alters in MSC the epigenetic states of micro-RNA (miR) miR-181a, a key miR that targets mitochondrial DNA
and negatively regulates their function. A consequent fall in levels of the mitochondrial derived peptide (MDP)
MOTS-c in turn impairs function and tissue repair capacity of MSC in obesity. To test our hypothesis, we will
define gene expression and epigenetic states of mitochondrial targeting miRNAs and MOTS-c in human
adipose tissue-derived MSC and elucidate their functional significance for both MSCs and their mitochondria.
Our Specific Aims will pursue 3 hypotheses. Aim 1: Human obesity induces MSC miR-181a expression and
in turn mitochondrial and MSC structural damage and dysfunction. Using RNA-seq we will identify miR-181a as
a key miR upregulated in MSCs from patients with obesity vs. healthy controls. Its role in regulating MSC and
mitochondrial function and structure will be assessed in vitro and in vivo (in mice with CLI or RAS) using novel
in vivo imaging and ex vivo techniques. Aim 2: Human obesity engages epigenetic mechanisms to alter miR-
181a. We will define the epigenetic landscape of miR-181a using MeDIP-seq, and its contribution to MSC
repair in vitro and in vivo using an epigenetic modifier. Aim 3: A fall in MOTS-c owing to mitochondrial damage
contributes to functional impairment of ‘obese MSC’. Using novel MDP-seq we will pinpoint MOTS-c as a
unique MDP linking mitochondrial to cellular integrity in MSC. MSC treated with MOTS-c peptide or neutralizing
antibody will be characterized, and restoration of ‘obese’ MSC function tested both in vitro and in vivo.
The proposed studies, employing cutting edge techniques, may uncover novel mechanisms underlying cell
damage and impaired repair in human obesity. These studies will advance understanding of the pathogenesis
of cellular damage, and likely contribute towards management of patients with obesity and vascular disease.

Public health relevance
Project Narrative Obesity induces chronic inflammation that triggers cellular damage involving multiple organs, possibly by damaging reparative cells that reside in tissues. We will test the hypothesis that obesity in human subject induces injury to fat tissue-derived reparative cells, which interferes with their capacity to mend injured mouse microvessels.